In silico screening for immune surveillance adaptation in cancer using Common Fund data resources

Summary/Abstract
Advances in immunotherapy have lately revolutionized cancer care. A key strategy of cancer immunotherapy is
to target “non-cell-autonomous” mechanisms of immune surveillance adaptation, achieved via regulating the
secretions of immune modulators from cancer cells. Yet, an in silico systematic screen for these targets and
immunomodulating agents (potentially therapeutic drugs) remains untested due to a lack of computational tools
to analyze relevant large-scale database resources. The study is proposed in response to RFA-RM-23-003 to
meaningfully integrate multiple NIH Common Fund and other NIH-funded datasets to inform the molecular basis
of immune surveillance adaptation and screen for potential immunomodulating agents. Our central hypothesis
is that cancer genomic features captured by deep learning predict cancer cells’ non-cell autonomous signals
induced by a compound treatment to modulate immune cells in the tumor microenvironment. We propose to test
the hypothesis by developing an innovative and feasible computational framework that is built upon our published
deep learning models. Specifically, in Aim 1.1 we propose to identify prognosis-related immune cell types and
associated immunologic gene signatures among adult (The Cancer Genome Atlas [TCGA]) and pediatric tumors
(Gabriella Miller Kids First [Kids First] and Therapeutically Applicable Research To Generate Effective
Treatments [TARGET]). We will then build a deep learning model to predict the perturbation of the identified
immunologic gene signatures induced by a compound in a cancer cell line using the Library of Integrated
Network-based Cellular Signatures (LINCS) data. In Aim 1.2, we will experimentally validate key findings using
our in-house in vitro models. We have formed a cross-disciplinary team with strong complementary expertise to
efficiently achieve the proposed goals: dry lab of Dr. Yu-Chiao Chiu (MPI) for cancer bioinformatics, multi-modal
data integration, and artificial intelligence; and wet lab of Dr. Yi-Nan Gong (MPI) for cancer immunology,
immunotherapy, and tumor cell death mechanisms. Successful completion of the pilot study will produce high-
impact preliminary results: i) the first deep learning framework that systematically incorporates multi-modal
genomic and pharmacogenomic data to screen for immunomodulating agents, ii) a deeper understanding of the
molecular basis of immune surveillance adaptation than was previously possible, and more importantly iii) a set
of promising targets preliminarily validated in vitro. These preliminary data will lead to a follow-up study to explore
functional and preclinical aspects of our results. We also expect the proposed study to provide a computational
framework that enhances the utilization and integration of NIH Common Fund data and other publicly available
large datasets.

Public health relevance
Narrative Cancer cells use multiple adaptation strategies to evade detection by the immune system, including secreting immune-modulating molecules such as cytokines and chemokines. Taking advantage of the Common Fund and other NIH-funded datasets (TCGA, Kids First, TARGET, LINCS, etc.), we will use computer analyses to systematically identify those cancer cell-secreted, immune-modulating molecules, especially those altered by compound treatments. Our work will provide insights into new anti-cancer immunotherapy development.